Addressing Evolving Infectious Threats

PROJECT SUMMARY/ABSTRACT
Society faces increasing threats from infectious diseases, from growing antimicrobial resistance to emerging
novel pathogens to pervasive misinformation about vaccines. A robust response including infectious diseases
physician-scientists is critical to meet these challenges, requiring diverse expertise from bench research to
social science and health policy research with translational relevance to infectious diseases. Our goal is to train
such individuals through the infectious diseases fellowship programs at the David Geffen School of Medicine at
UCLA. This T32 program will support MD or MD-PhD trainees who are pursuing subspecialty fellowships in
adult or pediatric Infectious Diseases seeking training for an independent research career. It will provide
dedicated mentorship and protected time to foster a pathway to independence. Required clinical training will be
front-loaded in the first year of the fellowship, leaving at least 85% protected time for two additional years of
dedicated research training and career development. Each fellow will select a mentorship team from any of the
broad and deep departments and research faculty at UCLA and affiliated academic institutions. A primary
research mentor will directly oversee research activities, and the team will provide complementary guidance on
the scientific project as well as the skills required for academic advancement including publishing, competing
for grant funding, and navigating career advancement in academia. This program will include four yearly slots
(two fellows each for two years of training) for MD or MD-PhD postdoctoral trainees. The key trainee outcomes
include producing publications/abstracts, obtaining career development funding (NIH K award or equivalent),
and eventual transitioning to an independent career as a physician-scientist.

Public health relevance
PROJECT NARRATIVE Infectious diseases pose emerging, ongoing, and evolving threats to society, and physician-scientists dealing with infectious diseases are crucial to meet these challenges. This T32 program will support the research career training of fellows enrolled in the adult and pediatric Infectious Diseases Fellowship Programs at the David Geffen School of Medicine at UCLA, who wish to pursue careers as physician-scientists. These trainees will have access to a breadth of infectious diseases-related research ranging from molecular virology to social science across any department at UCLA and its affiliated academic institutions.